Does traffic-related air pollution accelerate the development of the metabolic syndrome by impairing the resolution of neurogenic inflammation?

PROJECT SUMMARY
Metabolic disorders, including obesity and diabetes affect 1 in 3 individuals in the United States exacting a huge
cost on individuals and society. Epidemiologic studies have reported a positive correlation between exposure to
traffic-related air pollution (TRAP) and increased risk of metabolic disorders. Preclinical studies support this
association, but many of these studies used acute exposure to concentrated ambient particles or diesel exhaust
that do not recapitulate the complexity of chronic real-world human exposures to TRAP. Moreover, the
mechanism(s) by which TRAP increases individual risk for metabolic disorders remain speculative. We have
designed a unique exposure model in which rats are exposed in real-time to TRAP collected from a major
freeway tunnel system, which preserves the gaseous and particulate components of real-world TRAP and
captures daily fluctuations in pollutant levels. We will leverage this model to test our central hypothesis that
chronic TRAP exposure exacerbates metabolic disease by interfering with the resolution of neurogenic
inflammation. Using an established high-fat diet rat model of the metabolic syndrome, we will test whether chronic
TRAP exposure activates neurogenic inflammation in peripheral organs, initially in the lungs and subsequently
in organs involved in metabolic disease, such as the liver and adipose tissue. We hypothesize that chronic
activation of neurogenic inflammation tips the balance towards pro-inflammatory pathways and away from
inflammation resolution. In Aim 1, we will determine whether chronic TRAP exposure causes neurogenic
inflammation leading to increased pro-inflammatory (M1) and decreased inflammation resolving (M2)
macrophage phenotypes. Further we will characterize changes in the turnover of pro-inflammatory and pro-
resolving lipid mediators using deuterated tracers. In addition to examining the temporal relationships between
these outcomes, we will determine whether TRAP exacerbates metabolic disease, evidenced as a decreased
time to onset and/or increased severity of symptoms. In Aim 2, we will use a drug that blocks neurogenic
inflammation, and a drug that promotes inflammation resolution, to assess the causal relationship of TRAP-
induced neurogenic inflammation to both impaired inflammation resolution and symptoms of metabolic disease.
This will be determined by M1/M2 macrophage phenotypes and relative balance of pro-inflammatory and pro-
resolving lipid synthesis. Our broad long-term objectives are to understand how chronic exposure to TRAP
exacerbates the burden of metabolic disease, to inform regulatory and health interventions aimed at reducing
metabolic risk for individuals living, working, or attending school near busy roadways. This proposal is directly
aligned with the Notice of Special Interest (NOT-ES-20-018) goals of characterizing “cell and tissue specific
resolution phenotype in normal and disease models and the impact of exposure to environmental agents”.

Public health relevance
PROJECT NARRATIVE Exposure to traffic-related air pollution (TRAP) has been associated with an increased risk for metabolic disease; however, the mechanism(s) by which TRAP promotes or exacerbates this chronic disorder remain largely unknown. To address this data gap, we will leverage an established rat model of progressive metabolic disease to determine whether chronic exposure to TRAP, at human-relevant levels, accelerates metabolic disease development by impairing signaling pathways that normally function to resolve inflammation. These mechanistic studies are needed to corroborate human studies linking TRAP to increased risk for metabolic disease, and to inform regulatory and health interventions to reduce metabolic disease risk for individuals living, working or attending school near busy roadways.